SYNTHESIS OF NOVEL ANTICANCER AGENTS

Project Summary/Abstract: The proposed program focuses on synthesis of such complex natural products and their analogs by mimicking biological oxidative systems. Methods to form C-C bonds via oxidative C-H bond activation while establishing axial chirality will be developed using chiral oxidative catalysts. The possibility of selectivity in these transformations with respect to complex substrates is of significant synthetic potential. If such goals are realized, novel and unique synthetic strategies for the assembly of natural products can be envisioned. Routes to chiral binaphthyls, perylenequinones, bisanthraquinones, hypericins, and bioxanthracenes will be developed. The potential for photodynamic cancer therapy with the perylenequinone and hypericin structural types is especially noteworthy given recent developments in this area.

Public health relevance
Project Narrative: Small molecules will be synthesized for examination as anticancer therapeutics. In addition, the underlying chemical synthetic technology that is developed will be broadly useful in other contexts thereby facilitating the discovery and generation of new pharmaceutical agents.